Resolving heterogeneity in liver development

Project Summary
The definitive endoderm (DE) emerges during gastrulation as an epithelial sheet. This single cell sheet, which
produces the entire gut tube and associated organs, is patterned and differentiates into organ domains in
response to inductive cues provided by adjacent mesoderm-derived tissues. During induction, the hepatic
progenitor, the hepatoblast, emerges from the DE as a group of thickened cells that express hepatic markers.
The nascent hepatoblasts form a liver bud that will invade adjacent mesodermal tissue. Once invasion is
complete, a single midline rostral lobe and two smaller bilaterally symmetric caudal lobes are evident.
Although hepatoblasts and their associated mesoderm have each been regarded as uniform populations, we
have discovered remarkable heterogeneity in both. Firstly, hepatoblast arise from two spatially distinct DE
populations that each contributes uniquely to the liver bud. The ventral midline progenitors contribute mainly
to the hepatoblasts that populate the anterior liver bud while the bilaterally symmetric lateral progenitors
produce hepatoblasts that contribute to the posterior liver bud. Surprisingly, each progenitor has unique
requirements for this process and is each associated with different supportive mesenchyme upon induction.
For example, FGF signals are required to induce the sinus venosus bounded anterior hepatoblasts, while the
septum transversum mesenchyme bounded posterior hepatoblasts require BMP signaling to be induced
Furthermore, recent fate mapping from our group demonstrates that the anterior hepatoblasts mainly
contribute to the caudal lobes while posterior hepatoblasts mainly contribute to the rostral lobe. Finally
unpublished histological and molecular data suggests that the mesenchyme supporting the rostral and caudal
lobes are distinct tissues. Together these observations suggest that normal development follows two routes for
generating hepatoblasts. We hypothesize that the heterogeneity generated during early hepatic development
is essential for normal liver function and that it aids in generating the heterogeneity recently identified in
adult hepatocyte and cholangiocyte populations. Guided by the new developmental framework outlined
above, the aims of our proposal use our expertise in embryology and the power of mouse genetics to further
delineate this heterogeneity and to identify how it contributes to normal development. In Aim1 we propose to
use conditional knock-out strategies to assess how FGF and BMP signals contribute to hepatoblast induction in
vivo. In Aim2, we use an ex vivo approach and novel mouse reporters in vivo to uncover the developmental
origin and adult contribution of the rostral and caudal lobe mesenchyme as well as determine the molecular
signature of the rostral and caudal lobe hepatoblasts. The long-term goals are to understand how
developmental heterogeneity contributes to key adult responses such as homeostasis and regeneration and to
use these developmental insights to produce functional hepatic tissues in vitro.

Public health relevance
Project Narrative Although widely assumed to be a homogenous, recent data from my laboratory supports the novel hypothesis that the hepatic progenitor cells, termed hepatoblasts, are heterogeneous. The goals of this project are to our labs expertise in embryology and the power of mouse genetics to delineate the developmental processes that create and support this heterogeneity during normal development in the mouse. We believe that this new information will provide insight into mechanisms that support liver growth and regeneration and will provide new strategies for creating functional hepatic populations in vitro.